Investigating gene regulatory networks in immune cells of children who differ in susceptibility to malaria infection using single-cell approaches

Project Summary/Abstract
Malaria kills over 400,000 people annually, underscoring the need for a highly effective malaria vaccine. A better
understanding of immunity to Plasmodium falciparum, the most lethal of the human malaria parasites, in naturally
exposed populations can inform the rational design of more effective vaccines. However, reliable immune
correlates of protection against malaria remain elusive, and relatively little is known about immunity that prevents
P. falciparum infection given that sustained protection from parasitemia through natural malaria exposure is
rarely observed. In our K08-funded project, we have applied systems biology approaches to a unique subset of
children who remained free of P. falciparum parasitemia during a single malaria season despite intensive
surveillance consisting of PCR-based screening of blood collected every 2 weeks and during sick visits as well
as antibody evidence for parasite exposure during a 7-month surveillance period. This rarely observed
“aparasitemic” phenotype represents the closest approximation to sterile immunity in a naturally exposed
population and a unique opportunity to study host control of parasitemia. The goal of this R21 proposal is to
expand on findings from our prior bulk transcriptomic analysis of whole blood obtained from these aparasitemic
children using higher resolution technologies that include single-cell (sc) sequencing and multiparameter flow
cytometry. We propose using scRNA-seq on baseline peripheral blood mononuclear cells (PBMCs) obtained
from these children just prior to the surveillance period. When integrated with single-cell assay for transposase-
accessible chromatin sequencing (scATAC-seq), which assesses genome-wide chromatin accessibility to
identify “open” chromatin regions, scRNA-seq can also provide insight into the regulation of gene expression.
Combining integrated single-cell approaches with functional assays can help identify gene regulatory networks
within specific cell types that could serve as immune correlates of protection against malaria infection. We
hypothesize that, relative to parasitemic children, aparasitemic children will demonstrate increased antigen
receptor signaling within memory B and T cell subsets and enhanced P. falciparum-specific T-cell memory
responses despite having decreased proportions of T cells, which may reflect trafficking of T cells out of the
peripheral blood to target organs such as the liver or spleen. We will address this hypothesis with the following
specific aims: 1) to determine host immune genes that are differentially regulated and expressed using integrated
single-cell gene expression and chromatin accessibility profiling of PBMCs from malaria-exposed children who
differ in susceptibility to P. falciparum parasitemia and 2) to identify and characterize the immunophenotypic and
functional differences in PBMCs from children who differ in susceptibility to P. falciparum parasitemia. Successful
completion of these aims will help identify gene signatures and gene regulatory networks relevant to malaria
immunity that would form the basis of future studies aimed at elucidating the mechanisms of malaria-protective
cellular responses in humans.

Public health relevance
Project Narrative The complexity of the interactions between the human immune system and Plasmodium falciparum, the parasite responsible for the overwhelming majority of the ~400,000 annual malaria deaths, has impeded the development of a highly effective malaria vaccine. We propose using single-cell sequencing approaches to identify cell types and gene regulatory networks that may be important in controlling the parasite using samples collected from Malian children who remained free of parasitemia despite evidence of natural malaria exposure. Results from this study may lead to the identification of immune correlates of malaria protection and a better understanding of why sustained protection from parasitemia through natural malaria exposure is rarely observed.